Transposable Element Regulation and Expression During Cancer Progression

Project Summary
The expression of noncoding, repetitive regions of the genome termed Transposable Elements (TEs) have
shown strong preclinical potential as immunogenic agents that sensitize tumor cells to immune-modulating
therapies. Hypomethylation of the genome, dysregulated heterochromatin silencing, and mutations in regulatory
transcription factors results in elevated TE expression. Transcription of retrotransposons, a class of TEs that rely
on an RNA intermediate, result in type-I interferon (IFN) signaling and improve immune cell recruitment and
cytotoxic removal of tumor cells in cancer models including ovarian, colorectal, breast, and melanoma. However,
it remains unclear how durable interferon responses induced by TEs can be harnessed therapeutically.
Therefore, characterization of TE regulation and downstream activation of the type-I IFN response is critical to
improving the immunogenic potential of tumor cells.
In the F99 phase of this proposal, I will investigate how mutations in p53, a known regulator of TEs, derepresses
retrotransposon transcription in ovarian cancer. Specifically, I will determine how wildtype and R175H p53
differentially bind and recruit cofactors at TE loci. I will examine the viral signaling cascade activated by TE RNA,
known as MAVS/MDA-5, in both wildtype and R175H p53 settings to assess blunted signaling activation in
response to high TE transcription. Overall, this work will determine how mutations in p53 alter its chromatin
binding to derepress retrotransposons and identify how the ovarian tumor cells circumvent downstream IFN
activation.
In the K00 phase of this proposal, I will utilize my experience studying TEs to profile how disruptions in nuclear
architecture during tumor cell migration contribute to TE expression and type-I IFN signaling. I will compare
publicly available matched primary and metastatic RNA-sequencing data to assess TE derepression and type I
IFN signaling across metastatic events. I will validate the re-expression of TEs across metastasis using both in
vitro microfluidic micron-sized constrictions and in vivo mouse metastatic models. These models will determine
the impact of tumor cell migration on TE expression, implicate the disruption of nuclear lamina architecture to
TE derepression, and profile the activation of type I IFN.
The proposed research will inform the mechanisms of TE regulation and the downstream IFN response during
tumor evolution, and this will identify critical targets that mediate TE sensing needed to promote the immunogenic
potential of TEs as therapeutic targets in immunologically “cold” tumor types. These mechanisms will inform how
TE re-expression can further sensitize tumors to immune-modulating therapies to improve cancer patient
outcomes.

Public health relevance
PROJECT NARRATIVE Expression of immunogenic transposable element (TE) RNA has improved immune cell signaling and recruitment to the tumor microenvironment, however regulation of TEs and their downstream immune responses remain incompletely understood. Moreover, how the loss of nuclear compartment identity and tumor metastasis contribute to TE expression remain unknown. This proposal will examine transcription factor binding and nuclear lamina architecture on regulating TE transcription and the downstream immune responses to identify new targets for therapeutic intervention.